Molecular mechanisms of immune evasion in Staphylococcus aureus

In FY 2018, we continued our investigation of virulence factors that contribute to Staphylococcus aureus pathogenesis and immune evasion. The focus is on understanding which factors define the virulence potential of highly virulent MSSA and MRSA clones, in particular of community-associated MRSA. Much of our work is currently still focussed on phenol-soluble modulins (PSMs), toxins that we discovered in 2007. We collaborate with a series of researchers in different fields, analyzing the contribution of PSMs to different phenotypes. Current efforts in our own lab are aimed at understanding the regulation and export of PSMs. With regard to the former, we discovered in the past year that the PSM export system also confers resistance to human antimicrobial peptides.